Neural pathways for obesity development by AgRP neurons

Project Summary
The development of therapeutic drugs to cure obesity has not been successful due to unwanted side effects
and limited efficacy. My long-term research goal is to delineate neural pathways responsible for body weight
homeostasis, and provide a framework for effective and specific therapeutics against obesity. Research in the
last decades has identified arcuate neurons in the hypothalamus expressing agouti-related protein (AgRP) as a
key node in feeding. Recently, we and others demonstrate that chronic activation of AgRP neurons or adult
deletion of leptin receptors in these neurons leads to massive obesity on chow diet that is comparable to leptin
deficiency. AgRP neurons are known to release GABA, NPY and AgRP and send independent and parallel
projections to several key brain sites. Importantly, the expression of leptin receptor has been suggested to be
more prominent in those AgRP neurons that project to extra-hypothalamic areas. However, how the
neurotransmitters and the individual AgRP neuron projections mediate the obesity produced by chronic
activation of AgRP neurons are unknown. Additionally, how the individual AgRP neuron projections mediates
leptin action on obesity is also unknown
To address these knowledge gaps, we aim to examine the role of AgRP individual neurotransmitters (Aim 1),
projection-specific subpopulations of AgRP neurons (Aim 2) and their LepR expression (Aim 3) in mediating
the obesity development produced by chronic AgRP neuron activation. Advanced viral tracing and
intersectional mouse genetics will be used to achieve projection-specific manipulations in AgRP neurons to
achieve robust investigation. This proposal is based on our previously established massive obese mouse
models with chronic AgRP neuron activation or LepR deletion in AgRP neurons, and utilizes a combination of
inducible deletion and tracing to ex-amine the relative importance of individual transmitters and projections in
obesity development. The results will fill the gap in the underlying neurocircuit mechanism for AgRP neurons
on obesity development and will set up stages to identify key downstream mediators and neurons mediating
leptin and AgRP neurons in obesity development, representing a significant step in understanding brain
mechanisms in body weight regulation.

Public health relevance
Project Narrative One major reason for the current obesity epidemic and its associated lack of effective treatment is due to incomplete understanding of neuronal control of body weight. Using a combination of viral tracing and intersectional mouse genetics, the current proposal aims to dissect the role of distinct AgRP neuron projections that mediate the massive obesity development produced by chronic AgRP neuron activation. The results will identify brain circuit mechanisms for obesity and therefore form a foundation for effective treatments against obesity.